Core B: Alzheimer's Disease Down Syndrome Outreach Recruitment and Education (ADDORE)

ADDORE Core Abstract
There are numerous barriers to research participation in Down syndrome (DS) that are also complicated by
ethnoracial health disparities. A disproportionately higher rate of African American with DS die as young adults
when compared to Whites with DS and little is known related to differences in risk for a variety of age-related
diseases in DS, including Alzheimer’s disease. The overarching goal of the ADDORE Core is to generate
culturally and linguistically appropriate materials, in collaboration with community at large, for increasing
awareness and engagement of adults with DS from all communities into research aimed at understanding and
treating AD in this population. We will generate and disseminate educational materials regarding the importance
of research and research methods targeting AD in adults with DS and increase recruitment of individuals with
DS into the ABC-DS cohort from diverse populations and retain existing ABC-DS participants. Successful and
unsuccessful outreach strategies will be constantly monitored for updated best practices to be provided to the
scientific community. Increased enrollment of adults with DS from diverse populations and retention of existing
participants will be the metric for success. This core represents a near unique opportunity to engage
researchers and community stakeholders to inform best practices for increasing diversity and
engagement within the DS population